Striatal ensemble plasticity in alcohol use disorder

Relapse is a major clinical challenge in the treatment of alcohol use disorder. Relapse is driven in part
by alcohol-induced synaptic plasticity at the corticostriatal circuit. The dorsomedial striatum (DMS) has been
implicated in alcohol seeking and relapse. The DMS contains direct-pathway medium spiny neurons (dMSNs)
and indirect-pathway MSNs (iMSNs), which positively and negatively regulate alcohol seeking, respectively.
Alcohol-associated behaviors such as operant self-administration activate only a relatively small subset of
neuronal ensembles in the striatum. Although alcohol-induced plasticity is much studied in bulk tissue, it is
unknown whether it is induced in dMSN ensembles. Characterizing synaptic mechanisms of the ensemble
neurons is especially vital to reconcile with the decades of evidence for drug-induced synaptic changes detected
in bulk tissue analysis. In addition, extinction training yields greater suppression of alcohol seeking relative to
abstinence alone, but the mechanism is poorly understood. The absence of alcohol delivery during extinction
likely stimulates thalamic inputs to the DMS and reduces striatal dopamine levels, concurrently inducing
thalamostriatal long-term potentiation (LTP) in DMS iMSNs; this enhances “NoGo” actions, suppressing
alcohol seeking during relapse. LTP in iMSNs is also likely to directly or indirectly suppress dMSN activity by
reducing dopaminergic activity. This application aims to elucidate how extinction training reduces alcohol-
induced corticostriatal plasticity in the DMS ensembles and thereby persistently reduces relapse, with the long-
term objective of determining how such strategies can be used to treat alcohol use disorder. They hypothesize
that alcohol-induced corticostriatal plasticity in dMSN ensembles drives relapse and that extinction training
promotes thalamostriatal plasticity in iMSN ensembles to directly or indirectly, via counteracting dMSN
activity, suppress relapse. Three specific research aims will: 1) test the hypothesis that operant alcohol self-
administration causes long-lasting corticostriatal plasticity in DMS dMSN ensembles, promoting relapse; 2)
test the hypothesis that extinction-mediated thalamostriatal plasticity in DMS iMSN contributes to reduced
relapse to alcohol seeking; and 3) test the hypothesis that extinction training potentiates the inhibitory outputs
from iMSNs to dMSNs or the disinhibitory effects of iMSNs on habenula-projecting globus pallidus neurons,
suppressing relapse. This application is highly innovative because it applies state-of-the-art approaches,
including a combination of ArcTRAP, Cal-Light, and dual-channel optogenetic stimulation, allowing us for the
first time to determine how extinguishing alcohol-evoked synaptic plasticity in specific molecularly defined
neuronal ensembles alters their activities in vivo and thus persistently decreases relapse behavior; these critical
questions cannot be addressed using conventional methodologies. Knowledge generated from this proposal
will provide novel strategies for the long-term treatment of alcohol use disorder.

Public health relevance
Project Narrative While heavy alcohol intake causes long-lasting changes in the brain that are likely to contribute to pathological alcohol use and relapse, little is known about how to treat alcohol use disorder by reversing these changes. The studies in this proposal seek to reverse the connectivity between two brain cells recruited by alcohol drinking in animals by strengthening extinction-associated mechanisms to normalize the cell activity and thereby persistently decrease alcohol seeking and relapse. The results will provide new therapeutic approaches to reduce relapse to alcohol use.